Dissecting regulation and function of unc-6/Netrin via the generation of cis-regulatory alleles

Project Summary
The “Netrin system” has well-studied roles in axon pathfinding and less studied roles in synapse
formation in animals from worms to humans. I propose to study the relative contribution of UNC-
6/Netrin derived from multiple neuronal and non-neuronal sources by characterizing the expression
and phenotypic effects of cis-regulatory alleles of unc-6 in the nematode Caenorhabditis elegans. We
hypothesize that deleting different sections of the cis-regulatory region of unc-6 will result in alleles
that lose expression in subsets of neurons and non-neuronal cells, depending on the locations of
transcription factor (TF) binding sites that regulate expression in these cells. This work will enable me
to identify circuit organizer TFs and their binding sites that regulate unc-6 expression in different cell
types and neuronal circuits, and may enable me to distinguish between unc-6-expressing cells required
for axon guidance and synapse formation. To achieve these goals, I will pursue two specific aims.1)
Generate cis-regulatory alleles of unc-6. 3) Assess the functional consequence of neuron-type specific
expression of unc-6. I have identified the neurons expressing unc-6 in WT worms expressing an unc-
6::sl2::gfp::h2b reporter allele generated by CRISPR/Cas9-mediated genome engineering, using the
NeuroPAL system to identify individual neurons. I will generate cis-regulatory alleles of unc-6 by using
CRISPR/Cas9-mediated genome engineering to delete portions of the unc-6 cis-regulatory region, and
assess the which neurons lose expression in each cis-regulatory mutant. To assess the functional
consequences of neuron-type specific expression of unc-6, I will use reagents that enable the
visualization of neurites and synapses of neurons to assess the circuit-specific effects of unc-6 cis-
regulatory alleles on axon pathfinding and synapse formation. Through this work, I will elucidate the
regulation of unc-6, as well as its function in axon guidance and synapse formation in various neuronal
circuits. Through the pursuit of this project, I will develop skills in rigorous hypothesis-driven research,
literature review, written and oral communication of research results, and mentorship that I will need
to become an independent neurogenetics researcher. Dr. Hobert's lab and Columbia University are an
ideal environment in which to pursue the proposed project and my postdoctoral training. The lab has
made many impactful contributions to the neurogenetics field, Dr. Hobert has an excellent training
record, and Columbia University is a world-leading research institution at which neuroscience is a
major focus.

Public health relevance
Project Narrative UNC-6/Netrin plays vital roles in the directing of neuronal axons to their target cells, as well as in the formation of synapses, the connections between neurons that permit communication between them. It is unknown, though, whether the neurons that express unc-6/Netrin for the purpose of axon pathfinding are the same as those that express unc-6/Netrin to facilitate synapse formation. I propose to use the roundworm C. elegans to determine whether these two functions are separable and to characterize neuron-specific control of unc-6/Netrin expression, which may help me to elucidate the relative contribution of the lack of each of these functions in unc-6/Netrin-associated neurodevelopmental diseases.